Development of an antibody-oligonucleotide conjugate for treatment of Head and Neck Squamous Cell Carcinoma

Abstract:
In this Direct to Phase II SBIR application, miRecule proposes to develop MC-30 an Antibody RNA Conjugate
(ARC), composed of the anti-EGFR antibody cetuximab conjugated to a chemically modified mimic of the tumor
suppressor microRNA miR-30-5p. Head and Neck Squamous Cell Carcinoma (HNSCC) is the 6th most common
form of cancer worldwide. Greater than half of patients present with locoregionally advanced form of disease,
with an average 5-year survival rate of ~40%. Cetuximab is currently approved to treat this subset of patients
but only offers mild treatment benefit. This is partly due to EGFR targeted therapy often being compensated for
by overexpression of other growth factor receptors (GFRs) such as MET and IGF1R. However, we have
discovered that miR-30-5p simultaneously targets and repress all three of these GFRs. The rationale for miR-
30-5p replacement therapy is that it will be superior in its ability to treat heterogeneous late-stage HNSCC due
to its ability to regulate not only EGFR, but also MET, IGF-1R, and over two dozen other mRNAs confirmed to
be deregulated in tumor tissue and associated with proliferation, adhesion, migration, extracellular matrix
remodeling, and differentiation. MC-30 has three independent mechanisms of action, inhibition of EGFR
signaling and induction of ADCC by the cetuximab antibody component, and if the ARC is internalized
the RNA payload can suppress several oncogenic mechanisms and kill the cancer cell. We have
demonstrated in pre-clinical mouse models that MC-30 better than doubles tumor growth inhibition and
survival compared to cetuximab. We have also demonstrated that in preliminary toxicology studies that MC-
30 has a similar safety profile in mice and NHPs to the parent antibody. In this direct to phase 2 application we
will; 1) Validate MC-30 efficacy in diverse PDX and Syngeneic mouse models compared to standard of care. 2)
Execute process development and scale up of our MC-30 ARC and create a panel of CMC release tests for
GMP manufacturing. 3) PK Bioanalytical method tech transfer, and GLP validation for IND and Phase 1 studies.
4) Perform Non-GLP PK and maximum tolerated dose range finding studies in NHPs. Successful execution of
this proposal will finish our data package for our Pre-IND meeting with FDA, and subsequent initiation of IND
enabling studies.

Public health relevance
Project Narrative HNSCC is the 6th most common form of cancer. Greater than half of patients present with late stage III or IV disease, with an average 5-year survival rate of ~40%. In this Phase II SBIR study we will develop MC-30, an antibody RNA conjugate consisting of mimic of miR-30-5p coupled to anti-EGFR antibody cetuximab. MC-30 has the ability to down regulate key oncogenic pathway targets in HNSCC and overcome therapeutic resistance. Our novel ARC will offer an effective treatment of patients with unresectable, advanced HNSSC, and eventually for multiple multi-drug resistant cancers for which there are currently no treatment options and survival is measured in months.